MENSTRUAL CYCLE EFFECTS ON TOBACCO CESSATION SYMPTOMS

This study is designed to determine if the menstrual cycle phase effects symptom withdrawal and caloric intake in smoking cessation. Specifically, we are trying to determine if the phase of the menstrual cycle (luteal phase vs. follicular phase) has an effect on weight gain, caloric intake, nutrient content and resting metabolic rate. We are also trying to determine if withdrawal symptoms in smoking cessation are greater in the luteal vs. follicular phase. The Diabetes Control and Complications Trial (DCCT) study results were announced in June, 1993 and demonstrated that intensive treatment of type I diabetes with maintenance of good control of glycemia retarded retinopathy, nephropathy, and neuropathy. DCCT subjects continue to be followed as participants in the Epidemiology of Diabetes Intervention and Complications (EDIC).